Regulation of SAMHD1 antiviral activity

Project Summary/Abstract
Expression of the recently discovered human restriction factor SAMHD1 is responsible for the infection
block imposed to lentiviruses such as HIV-1, HIV-2 and SIVmac by primary macrophages, dendritic cells and
resting CD4+ T-cells. SAMHD1 blocks lentiviral infection by preventing the occurrence of reverse transcription.
SAMHD1 has deoxynucleotide triphosphohydrolase (dNTPase) activity, which degrades deoxynucleotide
triphosphates (dNTPs) into nucleotides and triphosphates, and this activity is required for HIV-1 restriction.
However, additional studies have revealed that the dNTPase activity of SAMHD1 is not sufficient for HIV-1
restriction. Thus, an additional property of SAMHD1 is required for HIV-1 restriction. SAMHD1 interacts with
nucleic acids in vitro, but the contribution of this interaction to HIV-1 restriction in vivo remains to be
determined. Our preliminary data using SAMHD1 mutants indicate that nucleic acid binding is important for
HIV-1 restriction. We determined the structure of SAMHD1 bound to an oligodeoxynucleotide and leveraged
this structure as a tool for structure-function studies. Several amino acids form the interface between SAMHD1
and the oligodeoxynucleotide, and mutation of these residues resulted in SAMHD1 proteins that are unable to
restrict HIV-1. These results suggest that the ability of SAMHD1 to interact with nucleic acids is important for
HIV-1 restriction. Separate from its antiviral activity, mutations in the human SAMHD1 gene cause Aicardi-
Goutières syndrome (AGS). AGS patients exhibit increased levels of type I interferon (IFN) that are believed to
result from the recognition of endogenous nucleic acids by innate immune sensors. Thus, it has been
suggested that the in vivo role of SAMHD1 is to prevent activation of the innate immune response by
endogenous nucleic acids, and the nucleic acid binding activity of SAMHD1 has been suggested to be
important for this function. Our preliminary data indicate that SAMHD1 knockout (KO) mice are resistant to
herpes simplex virus 2 (HSV-2)-induced limb paralysis and death. These results suggest that SAMHD1
prevents the recognition of HSV-2 by innate immune sensors, potentially by interacting with the HSV-2 viral
DNA and shielding it from detection. This strong phenotype in vivo will be used to unveil the role of SAMHD1 in
innate immunity. Based on these published and preliminary results, the central hypothesis of this proposal
is that the interaction of SAMHD1 with nucleic acids is important for its antiviral and innate immune
functions. Our rationale is that identification of the mechanisms by which SAMHD1 modulates viral infection
and innate immune responses will enable the development of novel antiviral and AGS therapies. To test our
central hypothesis, we will pursue the following specific aims: 1) Determine the mechanism by which SAMHD1
inhibits HIV-1 infection, 2) Evaluate the role of SAMHD1 acetylation in SAMHD1-mediated viral restriction, and
3) Characterize the role of SAMHD1 in innate immunity.

Public health relevance
The protein SAMHD1 is of substantial medical interest because it functions both as a viral restriction factor and a modulator of the innate immune response. Numerous biochemical and cellular properties of SAMHD1 have been investigated, and some of these properties have been found to correlate with SAMHD1 antiviral activity. However, how SAMHD1 is regulated and the mechanisms by which SAMHD1 exerts its effects, both on viruses and the innate immune system, are not fully defined. Filling these knowledge gaps is crucial for both identifying novel antiviral targets and developing therapeutic approaches for the treatment of AGS.